Research Education Component

RESEARCH EDUCATION COMPONENT - REC: PROJECT SUMMARY/ABSTRACT
The Research Education Component (REC) aims to expand the rich training enviroment at Johns Hopkins
Univeristy (JHU) by providing additional training opportunities for talented young investigators working in
Alzheimer’s disease and related dementias (ADRD). The goals of the REC are to: (1) select REC Scholars at
the Research Associate and Junior Faculty level, who will be provided with financial support, mentorship and
didactic training, with the goal of enabling them to become independent investigators working in ADRD; (2)
provide mentorship in ADRD research to young individuals at multiple early educational levels (including the
high school, undergraduate and post-baccalaureate students), through several ongoing training programs
aimed at individuals from underrepresented groups (URGs); (3) provide didactic training to graduate students
and postdoctoral fellows at JHU in ADRD research, in the form of a semester-long course entitled ‘Circuits
and Brain Disorders’, particularly aimed at attracting talented young diverse researchers to ADRD research,
who have not previously been working in the field; and (4) organize seminars and conferences that provide
an opportunity for researchers at all levels of accomplishment at JHU, and other local institutions, exposure to
important findings and innovations in the field. Through these efforts, the REC strives to strengthen training
opportunities at the Johns Hopkins Alzheimer’s Disease Research Center so that they reach a broad, diverse
cadre of young researchers, and continue to support the wealth of educational programs that have served to
integrate research and training in ADRD throughout the institution.